Elucidating function of disease-related SAMD9L mutations in hematopoiesis

Project Summary
Hereditary predisposition is the major etiological contributor to diseases leading to bone marrow failure (BMF) in
children. Recently, germline mutations in two interferon responsive genes, SAMD9 and SAMD9L (SAMD9/9L)
were shown to cause a group of multisystemic disorders with the common denominator of BMF with cytopenias
and a propensity for myelodysplasia. Overexpression of wildtype SAMD9/9L results in translation block and
cellular growth inhibition, and these phenotypes are exacerbated by patients’ gain-of-function (GOF) mutations.
The molecular mechanisms by which both wildtype and mutant SAMD9/9L proteins exert these activities are
largely unknown. Moreover, how the mutants impair hematopoiesis is limited by their cell toxic effect and lack of
experimental models. Towards this, by using CRISPR/Cas9 engineering, we have modelled two patient GOF
mutations (V1512M, V1512L) at a recurrently mutated SAMD9L amino acid residue, into the endogenous loci of
human-induced pluripotent stem cells (hiPSCs) and mouse (mouse V1507M/L). My preliminary analysis
exhibited decreased erythro- and myelopoiesis upon differentiation of mutant hiPSC-derived hematopoietic
progenitors, and significant anemia with B-cell lymphopenia in mutant mice, with increased severity of
phenotypes in V1512M genotype. Pilot gene expression studies showed a mitochondrial stress signature
depicted by upregulation of oxidative phosphorylation and reactive oxygen species pathways in mutants. Further
exploration into the mitochondrial phenotype revealed mutant-specific alteration of mitochondria network and
structure with swollen cristae by electron microscopy, with prominent defect in V1512M. This prompted the
investigation of a physiological link between SAMD9L and mitochondria, which I established by demonstrating a
strong co-localization of Samd9l with mitochondria in mesenchymal and hematopoietic stem cells (HSC) of
wildtype mice. Altogether, my work suggests SAMD9L to play a role in mitochondria biology. Since mitochondria
are critical for HSC homeostasis, differentiation, and commitment, I hypothesize that SAMD9L mutant-induced
hematotoxicity is mediated by the underlying mitochondrial dysfunction. I will pursue this hypothesis through two
specific aims: 1) interrogate the the variable effect of GOF SAMD9L V1512M and V1512L point mutations on
hematopoiesis in a in vivo murine model and 2) determine if SAMD9L V1512M and V1512L affect mitochondrial
structure, function, and dynamics. I will carry out the K99 phase of these aims in an exceptional research
environment under the guidance of Drs. Marcin Wlodarski and John Crispino, and my advisory committees
composed of experts in hematopoiesis, mitochondria biology, and immunology. In the independent phase, I will
extend my studies of the molecular link between SAMD9L and mitochondria in hematopoiesis and exploit
molecular reporters to refine this link. The institutional resources, academic environment and the planned
courses outlined in my proposal will ensure my successful transition to independence.

Public health relevance
Project Narrative We have recently established heterozygous gain-of-function (GOF) mutations in two interferon responsive genes, SAMD9 and SAMD9L (SAMD9/9L) as the major hereditary predisposition to childhood bone marrow failure and myelodysplastic syndromes. The molecular and functional consequences of these mutations on HSC biology and hematopoiesis is not completely understood. The proposed studies will use in vivo murine system and iPSC disease model to delineate the underlying mechanism by which GOF SAMD9L mutations cause hematopoietic defect.